The role of natural killer cells and antibodies in protection from malaria

Project Summary / Abstract
Malaria causes large numbers of deaths per year including 200,000 miscarriages due to placental malaria. We
lack an effective malaria vaccine partially because we do not fully understand the mechanism of antibody
mediated protection. Antibodies are predominantly thought to be effective through blocking mechanisms.
However, we hypothesize that protective antibodies in Plasmodium infection bind infected RBC surface proteins
for recognition and killing by natural killer (NK) cells. We have data showing that NK cells inhibit the growth of
Plasmodium in vitro through antibody dependent cellular cytotoxicity (ADCC). We went on to show that a subset
of NK cells, γ neg NK cells, have enhanced ADCC function and abundance of γ neg NK cells correlates with
reduced parasitemia and protection from malaria in a large endemic malaria cohort. This proposal aims to
understand how these γ neg NK cells increase function and abundance in the context of malaria infection. We
will test the CD16 cascade with CRISPR/Cas9 ablations to understand why γ neg NK cells have enhanced ADCC
function. We will use CRISPR/Cas9 to ablate effector and adhesion molecules to understand how NK cells inhibit
the growth of Plasmodium. We will also test the underlying mechanism of malaria exposure that drives the
increase in γ neg NK cells and test if γ neg NK cells expand with ADCC and malarial cytokine signals. We also
aim to define NK cell ADCC protective mechanisms against the placental malaria target Var2CSA. Var2CSA is
a protein on the surface of the infected RBC that adheres to the placenta and can cause miscarriages. We will
test if antibodies that are good at generating NK cell ADCC responses increase with Var2CSA exposure and
correlate with protective pregnancy outcomes in human and monkey samples. We will also test previously
identified and novel monoclonal antibodies for NK cell ADCC function and dissect the features that generate a
strong NK ADCC response. These aims in total will create a body of work that will contribute to the development
of better vaccines and therapeutics for malaria. This would change vaccine targets to be proteins on the surface
of infected RBCs instead of invasion proteins, predictive efficacy readouts would include NK cell ADCC assays,
and antibodies developed here may be future immune therapies.

Public health relevance
Project Narrative Malaria is still a major cause of death partially because we do not understand how antibodies protect. We recently found that natural killer (NK) cells could kill infected RBCs via antibody mediated cellular cytotoxicity (ADCC), and in an endemic malaria cohort, specific NK cells enhanced for ADCC activity correlated with decreased parasitemia and protection from malaria. This proposal builds on our findings to understand how these specific NK cells form and function, as well as understand how antibodies function to protect humans from malaria with the hope to improve vaccine design and efficacy readouts.